MAINTENANCE THERAPY WITH RECOMBINANT METHIONYL INTERFERON OR INTERFERON ALPHA 2B

Maintenance Therapy with Either Recombinant-Methionyl Interferon-Consensus One or Interferon Alfa-2b for AIDS-Associated Kaposi's Sarcoma.